ASH1L mediated transcription networks in autism spectrum disorders

Project Summary
Autism spectrum disorder (ASD) research has led to the discovery of highly penetrant mutations in chromatin
modifiers and transcription factors. However, given the large number of ASD risk factors, a major challenge for
ASD research is to establish convergent mechanisms that group apparently distinct genetic etiologies. We
identified a novel point of convergence between the histone-methyltransferase ASH1L, a major ASD genetic
risk factor, and a cluster of ASD high-risk genes (e.g. FOXP1, RIMS1, NRX1α). Transcriptional programs
modulated by ASH1L that lead to neuronal dysfunction are poorly understood. Our studies uncover a
transcriptional and epigenetic node linked to cell and circuit dysfunction underlying ASD phenotypes. Our
central hypothesis is that ASH1L counteracts Polycomb (PRC2) activity to orchestrate neuronal
development by modulating transcriptional programs governing synaptic function and neuronal
morphogenesis. We have observed that ASH1L-deficient neurons show significantly decreased levels of
FOXP1 expression, indicating transcriptional control of FOXP1 by ASH1L. It is therefore possible that this
relationship underlies overlapping features in the changes in brain structure and their associated transcriptional
networks caused by FOXP1 and ASH1L deficiency. In this Supplement, we will test the hypothesis that ASH1L
regulates transcriptional programs mediated by its downstream target, FOXP1, via inhibition of PRC2
activity. We will determine how FOXP1 contributes to the ASH1L mutant phenotype in two Aims. In Aim 1, we
will identify convergent and divergent mechanisms by characterizing the morphological and anatomical
phenotypes of ASH1L and FOXP1 mutant mouse brains. In Aim 2, we will define the relationship between
ASH1L and FOXP1 neuronal transcriptional networks, including the involvement of PRC2, by performing
transcriptomic analysis of ASH1L and FOXP1-deficient mouse brains. These Aims will not only provide clearer
insight into our studies of ASH1L-mediated mechanisms of neuronal development, but also constitute the
research training component of this Diversity Supplement for our post-baccalaureate research assistant. Funds
from the Supplement will allow our research assistant to integrate into our ASH1L research team while gaining
bench experience in histological techniques and advanced microscopy, molecular expression analysis and
bioinformatics. Along with conference activities and exposure to rigor, ethics, scientific communication and
elements of translational research, our assistant will receive career development training and guidance in
preparation for admission to a strong MD/PhD program in neuroscience research.

Public health relevance
Narrative Mutations in ASH1L are a major cause of autism spectrum disorder (ASD) and the ASH1L transcription factor regulates large groups of genes simultaneously, including other autism genes. We have identified FOXP1 as a gene controlled by ASH1L, suggesting a contributing role for FOXP1 in the ASH1L disease phenotype. This administrative supplement will allow us to define the functional relationship between ASH1L and FOXP1 by studying shared features in 1) brain structural changes and 2) gene expression changes in the context of ASH1L and FOXP1 deficiency.